Transcatheter Device for Congestive Heart Failure Treatment Through Left Atrial Decompression

ABSTRACT
Chronic heart failure (CHF) is a chronic and progressive condition that currently affects over 6 million patients in
the US. It accounts for over $35B in annual healthcare expenditure and is responsible for over one million
hospitalizations each year. CHF is a chronic and progressive condition in which the heart is unable to pump
enough blood to maintain adequate circulation - the heart is failing to meet the body’s needs. Approximately half
of all patients with CHF have a left ventricular ejection fraction greater than 40% and are categorized as having
heart failure with preserved ejection fraction (HFpEF, EF ≥ 50%) or mid-range ejection fraction (HFmrEF, 40%
≤ EF < 50%). The prognosis for these patients is poor: due to a paucity of treatment options, patients have 5-
year and 10-year mortality rates of 50% and 90%, respectively. Although existing pharmacological therapies
have demonstrated symptomatic improvement and mortality benefit in patients with HFrEF there are currently
limited FDA-approved treatment options (pharmacological or device-based) for the HFpEF patient population.
The concept of interatrial shunting has gained attention as a potential therapeutic option for patients with CHF.
By creating a connection between the high-pressure left atrium to the low-pressure right atrium elevated left atrial
pressure (LAP) may be effectively lowered thereby relieving CHF symptoms. Recently, several implantable
interatrial shunt devices have been shown to enable left atrial to right atrial blood flow, resulting in left atrial
decompression, a reduction in CHF symptoms, and improved quality of life in a number of promising human
clinical studies. Nonetheless intracardiac implants carry proven clinical risks including clot formation device
fracture, migration, and implantation failure. There is currently no device available that can provide therapeutic
left atrial decompression without the long-term clinical risks and concerns of leaving behind a foreign body in the
heart. Alleviant Medical has developed a novel transcatheter approach to relieve left atrial pressure by creating
an interatrial shunt without the need for a cardiac implant. Alleviant’s received FDA IDE approval following results
from device verification testing and results from the first-in-human clinical study to investigate the safety and
efficacy of a no-implant interatrial shunt for patients with heart failure. The goal of this proposal is three aims: (1)
to complete the testing of the ALV1 System, (2) develop necessary clinical screening and device procedure
training programs, and (3) submit a US PMA application to market the ALV1 System for alleviating symptoms
associated with elevated LAP in the HFpEF/HFmrEF patient population. To achieve this goal, Alleviant will
establish key verification test data demonstrating the reliability of the device in accordance with all internal risk
management and design control procedures and regulatory requirements. The Alleviant System is Class III in
the US and requires PMA approval. The methodology for this proposal will follow a risk-based product
development process and ISO Standard testing. Successful execution of this Phase IIB proposal will result in an
FDA PMA submission and commercialization of the ALV1 System.

Public health relevance
NARRATIVE Chronic heart failure is a chronic and progressive condition that currently affects over 6 million patients in the US and poses a major public health burden. Symptoms of the disease are due, in large part, to elevated left atrial pressure, which results from failure of the heart to adequately eject blood from its main pumping chamber (left ventricle). We propose a novel, non-implant medical procedure to relieve left atrial pressure through use of a simple, low-risk, minimally invasive catheter to thereby reduce the symptoms and morbidity associated with heart failure.